Career Development and Training Program

The purpose of the WRCE career development plan is to offer research and research support training opportunities, including individual Career Development projects and group Career Development activities. The individual Career Development Program will target junior faculty who wish to pursue a career in infectious diseases research. The overall goals will be to increase and strengthen the trainee's research skills and knowledge through a carefully mentored, individually tailored research program and research support activities. Multidisciplinary mentorship of career development trainees will be provided to ensure that research activities are adequately focused, and to provide assistance for the transition from basic discovery to product development, and eventually clinical evaluation. The overall goals of the Group Career Development program will be to increase and strengthen the trainee's knowledge and technical skills to support biodefense and emerging infectious diseases research. This program is intended to provide multidisciplinary opportunities for trainees, to ensure that the group activities are adequately focused, and to assist the transition from basic discovery to product development and clinical evaluation. In the initial grant year, group Career Development activities will be organized as a biosafety containment laboratory training program that will be designed to provide training opportunities to biodefense and emerging infectious disease researchers, including faculty, postdoctoral fellows, graduate students, and technicians to learn how to safely conduct research in biosafety level 2, 3, and/or 4 laboratories. A systematic and rigorous administrative and scientific management plan will be employed to allow for the selection of the most relevant and scientifically sound proposals, and for effectively monitoring and evaluating the program. The WRCE Director will have overall responsibility for the group Career Development activities and will designate the WRCE Associate Director to manage the plan. The Associate Director will be supported by the WRCE Program Administrator and other key WRCE Administrative Core personnel. All group career development projects will be evaluated for usage and value to the WRCE program. In addition, the plan will insure that the solicitation of project proposals is open and announced publicly, and that a special effort is made to recruit women and minorities.

Public health relevance
The WRCE individual Career Development program will contribute to training the next generation of scientists to become independent researchers, so that they may productively investigate biodefense and emerging infectious disease agents. The group Career Development program will train researchers, students, and technicians to understand and apply specific theoretical and practical biomedical research skills, such as the capability to safely perform research in biocontainment laboratories.